Pilot and Feasibility Program

Abstract/Summary – Pilot & Feasibility Grants Program
The UT Southwestern Nutrition and Obesity Research Center (UTSW NORC) Pilot & Feasibility Grants
Program (P&F) will foster research on the genetic, physiological, nutritional, and behavioral determinants that
regulate energy balance and metabolism. This includes studies investigating the pathophysiology of obesity
and the effects of altered composition and quantity of nutrients to impact intermediary metabolism and
modulate disease risk. We will also support studies aimed at developing novel interventions to reduce obesity
and associated comorbidities. To achieve this goal, we will provide opportunities for both new and established
UT Southwestern investigators to generate sufficient preliminary data for a successful application for major
research funding from NIDDK or other national granting agencies. The $100K/year for the UTSW NORC P&F
grants program will fund up to 4 applications each year. These awards will be important for recruiting and
fostering new investigators to the field. We also strongly believe that given the nutrition and obesity research
expertise at UT Southwestern, these awards will result in considerable return of new funded NIDDK awards,
new collaborations among UTSW NORC members, and most importantly, significant advances in the field
that will lead to new therapeutic opportunities.